Identifying novel molecular targets, signaling pathways and mechanisms underlying fentanyl overdose-induced severe respiratory depression and lethality in rats using TMT phosphoproteomics/proteomics

Project Summary/Abstract
Fentanyl is a potent synthetic, lipophilic phenylpiperidine analgesic that primarily acts through the Oprm1 Exon
1 (E1)-associated full-length 7TM mu opioid receptors (MORs). Fentanyl has its unique pharmacology that
distinguishes from opium-derived mu opioids such as morphine and heroin, which includes its faster onset and
higher potency. Our preliminary studies showed that a lethal dose of fentanyl (10 mg/kg, i.v.) had no effect on
persistent apnea, muscle rigidity and lethality, but induced modest respiratory depression in our Oprm1 E1-KO
(rE1d/d) rats, suggesting that fentanyl overdose-induced severe respiratory depression (FOISRD), persistent
apnea, muscle rigidity and lethality are primarily mediated through MORs with additional non-MOR mechanisms,
particularly of the respiratory depression, in our rat models. Respiratory regulation in mammalians is very
complex and dynamic and involves coordination among multiple brain regions and several peripheral tissues
such as the lung and carotid body at the molecular, cellular, and network levels. MORs are widely expressed at
these sites. Increasing evidence has indicated that MORs play an essential role in mediating opioid-induced
respiratory depression (OIRD). However, the molecular mechanisms and related signaling pathways underlying
FOISRD and other toxicities via MORs or non-MOR systems remain largely unknown. Reversible protein
phosphorylation by protein kinases and phosphatases is one of the most important post-translational
modifications that plays a fundamental role in regulating almost all physiological and pathological processes. Mu
opioid-induced phosphorylation occurs very rapidly, commonly within seconds or minutes, dynamically shaping
the signaling. However, we know little about in vivo phosphorylation induced by mu opioids, particularly by
fentanyl overdose. Our preliminary data using tandem mass tags-based phosphoproteomics/proteomics (TMT
PP/P-omics) showed that fentanyl overdose can rapidly modify phosphorylation status of many signaling
molecules, some of which likely contribute to FOISRD, persistent apnea, muscle rigidity and death. These data
strongly support our overarching hypothesis that fentanyl overdose induces differential phosphorylation of crucial
signaling molecules in multiple brain regions and peripheral tissues via MORs or non-MOR system and
subsequently alters their related signaling pathways, leading to severe respiratory depression, persistent apnea,
muscle rigidity and lethality. To test the hypothesis, we proposed the following Specific Aims: (1) Examine
fentanyl overdose-induced phosphoproteins/proteins' changes in multiple brain regions and peripheral tissues
of our rat Oprm1 gene targeting models using TMT PP/P-omics; (2) Identify molecular targets and signaling
pathways that are responsible for FOISRD from selected candidate phosphoproteins from TMT PP/P-omics
study. The proposed studies well fall into the goal of this specific RFA and promise to identify novel molecular
mechanisms underlying FOISRD, persistent apnea, muscle rigidity and lethality and may identify the potential
molecular targets for developing novel therapeutic strategies to combat FOISRD and fentanyl overdose death.

Public health relevance
Project Narrative Fentanyl and its analogs have been associated with two thirds of the United States opioid overdose deaths in recent years. Fentanyl acts primarily through mu opioid receptors (MORs). The proposed studies aim to identify novel molecular targets, signaling pathways and mechanisms underlying fentanyl overdose-induced respiratory depression, persistent apnea, muscle rigidity and lethality via MORs or non-MOR system at the protein phosphorylation level in rats.